Promoting the "Good Life" among Nursing Home Residents with Alzheimer's Disease and Related Dementias: The Role of Special Care Units

Project Summary/Abstract
Many adults over age 65 with Alzheimer’s disease and related dementias (ADRD) reside in nursing homes (NHs)
to receive advanced medical care and supervision as the diseases progress. Yet, numerous NHs are struggling
with best practices in the delivery of care to residents with ADRD. NH Alzheimer’s special care units (ASCUs)
are one potentially promising feature in some NHs related to better resident care and outcomes. However, we
are yet to understand what is ‘special’ about these units and the characteristics and care practices associated
with beneficial outcomes and improved quality of life. This Pathway to Independence proposal will contribute
substantially to our understanding of how to ensure the “Good Life” among residents with ADRD in a novel,
structured, and evidence-informed approach, establishing the candidate as an emerging leader in health services
research committed to advancing research on care for persons with ADRD. The data obtained in Aim 1 of this
proposal will provide critical first-hand experiences from residents with ADRD, their families, and nursing staff
providers on quality of life and care practices among this population. These findings will be integrated into an
evidence-informed “Good Life” model of NH care in Aim 2 and implemented and evaluated in Aim 3 in a small
but rigorous randomized controlled clinical trial. These Aims are well-aligned with NIA priorities including
challenges and burdens associated with caregiving, models of care in long-term supports and services,
disparities in health care access, and promoting health in persons with ADRD. Collectively, knowledge gained
in this proposal will inform a subsequent R01 application to conduct a more definitive examination of the “Good
Life” model of NH care. Findings will also have implications for persons with ADRD and their families, NHs, policy
makers, and researchers on how to promote the “Good Life” in long-term care communities. To promote this
Pathway to Independence, the candidate has established commitment from an exceptional, highly accomplished
mentorship team of leading experts in long-term care research, conducting pragmatic clinical trials in NHs,
qualitative and quantitative methodology, and direct resident care. Importantly, these members have successful
current and prior collaborations amongst themselves and with the candidate, one even serving on the candidate’s
dissertation committee. In addition to the innovative research Aims, this proposal will pursue rigorous training
and career development activities designed to complement and further the candidate’s skills in key research
areas: qualitative methods, pragmatic clinical trial design, translational and implementation science, caregiver
shadowing in NHs to observe direct resident care, grant writing, teaching, and scholarly presentations and
publications. The University of Maryland, School of Social Work is pleased to support this proposal and all related
activities for the candidate. This Pathway to Independence proposal is the natural and necessary next step to
establish the candidate as an independent interdisciplinary health services researcher and leader committed to
identifying, optimizing, and disseminating best care practices for persons living with ADRD.

Public health relevance
Project Narrative Until there is a cure for Alzheimer’s disease and related dementias (ADRD), one of the greatest research challenges of our time is to improve the quality of care and life of persons living with ADRD, especially the high proportion residing in nursing homes (NHs). This Pathway to Independence proposal will utilize novel, evidence- informed approaches to examine the ‘special’ features of NH Alzheimer’s special care units and translate findings into actionable care practices to improve care and outcomes among residents with ADRD in NHs nationally. Findings will contribute substantially to our understanding of best care practices among this population and provide innovative insights into promoting the “Good Life” among residents with ADRD in long-term care communities.